Using Innovative Machine Learning to Detect Organized Support and Opposition to E-cigarette Use Prevention Campaign Messaging on Twitter and TikTok

Using Innovative Machine Learning to Detect Organized Support and Opposition to E-cigarette Use
Prevention Campaign Messaging on Twitter and TikTok
In recent years sharp increases in the consumption of non-cigarette tobacco products, including vaping
products or electronic nicotine delivery systems (ENDS), have largely offset the significant decline in cigarette
smoking rates in the US over the past five decades. In response, several state, local and federal tobacco
control programs have developed prevention campaign messages for youth vaping and e-cigarette use. Some
of these campaigns have also provoked significant opposition on social media from tobacco harm reduction
advocates.
Strong evidence supports the effectiveness of anti-smoking media campaigns in preventing youth cigarette
smoking, but little research has examined the effects of campaigns that aim to prevent other types of tobacco
use, such as anti-vaping campaigns. Further, previous evidence about prevention campaign effects did not
take into account the current cluttered media environment, where campaign messages compete for audience
attention with tobacco product promotion messages and both supportive and oppositional messaging about the
campaigns themselves.
Thus, social media interventions to prevent e-cigarette use are necessary but have unknown potential
effects in a competitive communication environment characterized by an influx of ENDS product marketing and
advocacy, potentially resulting in audience confusion and misinformation.
Therefore, measuring engagement with e-cigarette use prevention campaigns on social media and
understanding the patterns of such engagement and information flow represent important advancements in the
science of prevention and lend evidential support for tobacco regulatory policy. The proposed project will
assess the e-cigarette use prevention-related content amount, reach, and engagement on social media (Aim
1); identify sources and major themes associated with both supportive and oppositional messages using
machine learning (Aim 2); and apply social network theories and approaches to examine patterns of social
media users’ information seeking, exposure, dissemination, and gatekeeping in the campaign periods over
time (Aim 3).

Public health relevance
PROJECT NARRATIVE Social media have been increasingly used to disseminate e-cigarette use prevention messages, however, very limited research has comprehensively examined the amount, themes, and sources of these campaigns and the social networks embedded in the campaign conversations. This project will fill this gap by measuring reach and engagement of such campaigns and analyzing comparative themes, major strategies countering these interventions, and the social networks upon which campaign effectiveness depends. These insights will then be used to develop concepts and technologies to help create effective social media campaigns preventing e-cigarette use among youth and young adults.